Development of Mi-Helper: A Thermodynamic Neuromodulation Device for Migraine Relief

ABSTACT
Migraine is a severely disabling neurologic condition and the second most disabling disorder worldwide, affecting
over a billion people. The prevalence of migraine in the U.S. is increasing, with 15% of the population suffering
from either episodic or chronic migraine. The global economic burden of migraine is staggering, at approximately
$20 billion in the U.S. and $56 billion worldwide per year. Migraine is one of the most common reasons for
emergency room visits. Despite first-line treatment recommendations, many migraine patients are still prescribed
opioid pain medications, particularly in emergency departments (EDs). There is an enormous unmet need for an
effective and affordable non-drug abortive therapy for acute migraine to significantly improve quality of life and
substantially reduce the cost burden to our healthcare system and society.
CoolTech has developed the Mi-Helper device - a novel approach to migraine treatment that is simple, safe, and
drug free, using nothing but clean, dry air. Mi-Helper induces thermodynamic neuromodulation by a low flow of
dry, ambient air across the nasal turbinates. This approach targets the sphenopalatine ganglion (SPG), a nerve
bundle behind the upper airway that is associated with migraine symptoms. Evidence has shown that SPG
inhibition, including the use of intranasal lidocaine, can reduce the pain and duration of migraines. However, the
location of the SPG makes it hard to access to apply anesthetics and requires a skilled physician to administer.
Neuromodulation by way of transnasal cooling is an approach that provides fast, convenient, drug-free symptom
relief. We have demonstrated proof of concept of this technique’s capacity for pain and symptom reduction in
multiple in-clinic, feasibility studies and in a decentralized, double-blinded, randomized controlled study in which
the sham was confirmed, blinding was effective and a range of doses were tested to determine the most effective
dose that was statistically significant compared to the control. Upon commercialization, Mi-Helper will offer a
fast, low-cost, non-invasive treatment designed for on-demand use in an at-home setting at the earliest sign of
onset.
In this Direct to Phase II SBIR, CoolTech will conduct a double-blind, decentralized, randomized, sham-
controlled clinical trial to demonstrate the safety and confirm the optimal dose of Mi-Helper as an acute treatment
for episodic migraine, as well as optimize the usability of Mi-Helper for the target population. Additionally,
CoolTech will implement design enhancements to improve the Mi-Helper device, focusing on reusability of key
components, which will enhance usability, affordability, and functionality. These improvements aim to increase
the benefits to migraine patients and strengthen the Mi-Helper's competitive position in the market.

Public health relevance
Project Narrative Migraine is a severe and debilitating neurological condition that affects over 39 million Americans. The primary method of treating migraine is with pharmaceuticals, which have limited efficacy, troublesome side effects and the potential for overuse. This project will develop and clinically validate a new product, Mi-Helper, which is a noninvasive, quick, easy-to-use product that migraine sufferers can use at home to receive relief from migraine attacks.